Collaborative Action for Research to End Stillbirth (CARES)

PROJECT SUMMARY
Stillbirth is far too common in the U.S. with 20,000 stillborn babies every year with large racial and ethnic
disparities. Black birthing individuals have twice the risk of stillbirth compared to White individuals. The
Collaborative Action for Research to End Stillbirth Research Center (CARES) will conduct innovative,
integrated, multilayered research - with and for people with lived experience of stillbirth squarely at the center-
to develop and implement actionable strategies to improve the prediction of stillbirth early in pregnancy and to
understand reasons for the excess risk for Black birthing individuals. We propose to address a critical area in
stillbirth care – early identification of patients at highest risk for stillbirth to facilitate prevention. Screening patients
early in pregnancy is important as 63% of stillbirths occur before 32 weeks of gestation. Joining efforts from
researchers across essential disciplines, people with lived experience of stillbirth, and community, public health,
and health care stakeholders, CARES will address the following Specific Aims: Aim 1. Establish a strong
infrastructure to support stillbirth research and collaboration across the consortium. With input from the
CARES Stakeholder Advisory Board and the CARES Parent Advisory Board, we will develop and maintain a
core team of investigators, collaborators and staff with expertise essential for a broad range of stillbirth-related
research. We will also build shared resources to promote interdisciplinary team science and ensure access to a
diverse patient population to facilitate stillbirth research. Aim 2. Develop a scalable, electronic health record
(EHR)-based, dynamic risk prediction model for stillbirth. Inadequate data sources have been identified as
a major barrier to advancing knowledge on stillbirth and its prevention. We will (2a) Ascertain patients’ and health
care professionals’ perspectives on risk factors for stillbirth (overall and for Black birthing individuals specifically),
data needs for stillbirth research, and the acceptability and design of a mobile app-based patient data reporting
tool to support pregnancy monitoring and stillbirth prediction; (2b) Develop and validate EHR-based and artificial
intelligence-powered algorithms for automated identification and characterization of stillbirth, measurement of
stillbirth risk factors, and prediction of stillbirth risk scalable across institutions; (2c) Develop and test a mobile
app for patient-reporting of pregnancy information to augment EHR data and support pregnancy care. Aim 3.
Develop novel markers of underlying incipient placental dysfunction early in pregnancy for predicting
stillbirth. Fetal growth restriction (FGR) is a major antecedent to stillbirth with the most common underlying
pathogenesis being placental dysfunction. Accurate identification early in pregnancy and management of FGR
could potentially make an impact on stillbirth prevention. We will conduct a prospective cohort study to investigate
innovative (3a) placental imaging before 14 weeks’ gestation, (3b) placental biomarkers, and (3c) fetal genetic
markers for predicting fetuses at greatest risk for stillbirth. CARES will use multifaceted approaches applicable
to the entire population of birthing people to prevent stillbirth.

Public health relevance
PROJECT NARRATIVE The stillbirth rate in the U.S. remains persistently higher than other high-income countries with Black birthing individuals having twice the risk of stillbirth compared to White individuals. Innovative methods to improve the prediction of stillbirth early in pregnancy are urgently needed to enhance opportunities for prevention. Understanding the reasons for disparities in stillbirth risk can inform interventions to reduce the excess risk for Black birthing individuals.